Estrogen and Immunoprotection in Experimental Stroke

PROJECT SUMMARY Our work over the last fifteen years emphasizes that the cellular and molecular pathobiology of cerebral ischemia is strongly influenced by sex and by estrogen deficiency. This renewal application targets an exceptionally understudied area of stroke research that will be of interest to stroke nursing: interactions between the recovering brain and stroke-induced immune dysfunction in the female. It is now increasingly clear that human stroke results in multi-organ systemic disease, rather than in solely brain damage. While patients may survive the initial brain insult, many succumb to CNS injury-induced immunodepression and fatal infection. In animal-based studies, stroke-induced immunopathology is a bi-phasic molecular process of first stimulation, then degeneration, of lymphiod tissue that houses immune cells. Because all previous work has been conducted in male animals or in cells derived from male tissue, we know virtually nothing about these processes in the female. Our overall hypothesis is that focal stroke leads to abnormal activation of splenic immunocytes, particularly T lymphocytes that have a regulatory phenotype (CD4+CD25+FoxP3+ Treg cells) and ordinarily provide endogenous immunosuppression. Subsequently, there is a progressive apoptosis of the spleen, with broad destruction of most constituent immunologically competent cells but a sparing of Treg cells. We hypothesize that this relative overabundance of Treg cells mediates post-ischemic, systemic immunosuppression in the surviving animal. Invasion by splenic lymphocyte subsets into injured brain also results in two opposing contributions: 1) enhanced local inflammation and macrophage recruitment by non-Treg cells yet 2) a limiting of T cell-mediated brain damage by Treg cell suppressive mechanisms. In the female operating in an estradiol (E2)-depleted physiology, this pathology is exacerbated and puts the animal at exceptional risk. We propose to: 1) determine if peripheral immune dysfunction occurs in tandem with cerebral inflammation after focal cerebral ischemia (middle cerebral artery occlusion or MCAO) in the young adult and middle aged, reproductively senescent (RS) female mouse. The hypotheses are that a) focal stroke leads to early splenic activation, cytokine-mediated splenic apoptosis and loss of cell-mediated immunocompetence and b) estrogen deficiency exacerbates this pathology; 2) determine if peripheral T lymphocytes play a significant role in post-ischemic brain and spleen tissue outcomes and in behavioral deficits in the female. The hypotheses are: a) the T cells that contribute to stroke damage are specific for brain antigens, b) blocking translocation of non-Treg cell subsets to brain improves brain outcome and c) conditional deletion of Foxp3+ T reg cells aborts splenic destruction but at the high cost of increased brain injury; 3) evaluate a novel G protein-coupled estrogen receptor 30 (GPR30) agonist for neuro- and immunoprotection after MCAO in the female. The hypothesis to be tested is that GPR30 agonist G1, like E2, alters Treg induction, mitigating immunosuppression while concurrently protecting the recovering brain.

Public health relevance
PROJECT NARRATIVE Stroke is a major killer of women in the US. Our study is focused on developing therapy that will improve brain outcomes and immune system function after stroke in females. We will also explore the effects of estrogen deficiency and restoration on post-stroke immunity.